Investigation of the urban-social exposome on maternal depression

Project Summary/Abstract
Maternal depression affects approximately one in six new mothers worldwide. Left untreated, there is an
increased risk of adverse child development, self-harm, partner/marriage dissolution, and self-medicating,
which can lead to disastrous effects on the mother, child, and family. Despite its prevalence, the multifactorial
etiology of maternal depression and the underlying biology is poorly understood. Emerging evidence indicates
that stress (i.e., social exposome) and the built environment (i.e., urban exposome) may be causal factors in
depression through affecting key biological pathways such as inflammation, hormones and steroids, and
tryptophan metabolism. Indeed, our preliminary data links PM2.5 exposure (i.e., particulate matter with diameter
<2.5 μm) with maternal depression and demonstrates that psychosocial stress during pregnancy exacerbates
maternal depression. However, a study of the complex interactions between the multi-level, built environment
and psychosocial factors that describe urban living during pregnancy—built environment (i.e., PM2.5, NO2,
noise, light-at-night, greenness, temperature, noise, and population density) and multiple stress constructs
(i.e., negative life events, salivary cortisol, and coping mechanism)—have not been robustly investigated. We
will address this gap using rigorous epidemiologic and statistical methods. We will leverage the Programming
Research in Obesity, GRowth, Environment and Social Stressors (PROGRESS) longitudinal birth cohort,
which includes a comprehensive questionnaire and biological measures of psychosocial stress, high
temporally- and geo-spatially resolved built environment measures, and longitudinal maternal depression
phenotyping and biospecimen collection from pregnancy until 14 years postpartum. To address multiple mental
health constructs, we will characterize maternal depression across this critical decade of maternal life using a
validated questionnaire (longitudinal EPDS collected 12 times) and the gold standard in clinical depression
diagnosis (SCID-5). We will use state-of-the-art satellite remote and ground sensing models to investigate the
impact of the urban exposome during pregnancy on the risk of maternal depression (postpartum, depression
progression over 14 years, and clinical depression up to 14 years post pregnancy). We will then determine the
role of the social exposome alone and in combination with the urban exposome on maternal depression risk.
We will use our metabolomics platform to simultaneously measure key neuro-immuno-endocrine metabolites in
a single assay to identify metabolic changes that link the urban–social exposome with depression. Our
population of 600 mothers in Mexico City with high but variable exposures to the urban–social exposome
provides a unique opportunity to investigate the complexity of modifiable risk factors of urban life and early
biomarkers of maternal depression. This will significantly enhance our knowledge of when, where, and how to
intervene to reduce the risk and incidence of depression.

Public health relevance
PROJECT NARRATIVE Little is known about the complex etiology of maternal depression. We will identify triggers of maternal depression in a birth cohort of 600 mothers in Mexico City with 14 years of data that includes analysis of the built environment (e.g., PM2.5, NO2, noise, light-at-night, etc.), psychosocial stress, and metabolites related to inflammation, steroids and hormones, and tryptophan metabolism in maternal serum samples. These data will allow us to determine how the complexities and challenges that come with urban living impact maternal depression, which will significantly enhance our knowledge of when, where, and how to intervene to reduce the risk of depression.